Enteric Pathogen Force of Infection among Children using Serology

Enteric pathogen infections are a leading cause of the global disease burden, with the largest burden among
children in low-resource settings. Stool-based PCR methods have dramatically improved our ability to measure
enteric infections, but the challenge of collecting stool and need for near-continuous monitoring to detect many
globally important pathogens has thwarted broader use in large-scale surveillance. Large-scale, population-
based surveys now regularly collect blood to monitor transmission and burden of diseases such as HIV, malaria
and dengue. Broader testing of blood collected in such surveys with multiplex assays represents a new
opportunity to measure enteric pathogen transmission and burden. Antibody-based measures could complement
stool-based PCR testing because antibody responses remain elevated for many months after infection, thus
providing more information in studies with infrequent measurements. Our team has developed multiplex bead
assays that measure immunoglobulin G (IgG) response to diverse enteric pathogens. In preliminary studies we
have shown that IgG levels can be used to measure heterogeneity in enteric pathogen transmission between
populations. We have also shown the results generalize to pathogens that span taxa. In this application, we
propose to complete a series of studies that address key next steps to advance the seroepidemiology of enteric
pathogens in low-resource settings. We will conduct a longitudinal birth cohort in Ecuador that pairs high
resolution, multiplex stool-based PCR infection with longitudinal, multiplex IgG and IgA measurements. Our 17-
year research history at the site has documented substantial variation in enteric pathogen infection across a
rural-urban gradient, making it an ideal setting for the research. The cohort will enroll 600 children from three
sites across a rural-urban gradient, and measure them frequently from birth to 24 months. On the Luminex
platform, we will pair multiplex PCR assessment for 15 enteric pathogens with IgG and IgA assessment in a
multiplex bead assay that includes antigens to 7 enteric pathogens: Campylobacter jejuni, enterotoxigenic
Escherichia coli, Salmonella enterica, Giardia duodenalis, Cryptosporidium parvum, Entamoeba histolytica, and
norovirus. In Aim 1, we will use molecular and antibody-based measures to study force of infection of the enteric
pathogens across a rural-urban gradient. This will represent the first broad-based comparison of
seroepidemiologic measures against patent infection for enterics. In Aim 2, we will estimate enteric pathogen
force of infection by applying current-status models to population-based, cross-sectional serology surveys in the
region, and will benchmark the cross-sectional estimates against those obtained in the concurrent longitudinal
study. In Aim 3, we will study IgG and IgA kinetics following infection for each of the 7 pathogens, and develop
models to accurately predict recent infections and incidence from antibody levels measured in cross-sectional
serology surveys. Completion of these aims will result in generalizable seroepidemiologic methods that have the
potential to transform measurement of enteric pathogen transmission and burden in low-resource settings.

Public health relevance
Project Narrative / Lay Language Description Pathogens that cause diarrheal disease account for an immense global public health burden, primarily among young children in low-resource settings. The use of antibodies to study the epidemiology of diarrhea-causing pathogens has potential to improve our measurement of pathogen transmission in research and surveillance. This project will advance the epidemiologic methods used to measure diarrhea-causing pathogen exposure at the population level, by completing the first comprehensive study that pairs antibody-based and stool-based measures of infection among a birth cohort living across a rural-urban gradient in Ecuador.